The Effects of New E-cigarette Internet Sales Bans and E-cigarette Flavor Bans on Tobacco Use by Youth, Young Adults and Adults

Project Summary
Use of all tobacco products by youth and young adults up to age 25 poses a serious public health
concern because this group is at risk of long-term health effects and neurological damage from nicotine
exposure. Interventions targeted at them to discourage tobacco use can help lower the trajectory of nicotine
addiction and use of other addictive substances over the life cycle. Reducing their access to e-cigarettes and
altering appealing attributes of e-cigarettes are among the cornerstones of a strategic prevention policy
framework. The proposed research will provide the first plausibly causal evidence on the effectiveness of two
key policies in affecting tobacco use by youth, young adults and adults. These regulations are: 1) a ban on
internet sales of all e-cigarette products; and 2) a comprehensive ban on all added flavors in all e-cigarette
products – including those exempt from the current federal ban. Internet sales bans have just been enacted at
the federal level although there is no empirical evidence speaking to its causal effect on e-cigarette use.
These new bans are intended to target youth and young adults, but they apply to all sales. As a result,
spillovers of the policy effects to adults are possible. Because e-cigarettes are potentially beneficial to adult
smokers who are trying to quit smoking, it is important to ascertain whether these bans mainly affect youth and
young adults or also have any spillover effects on adults and in particular adult smokers. We will assess such
potential spillovers of internet sales bans, and comprehensive flavor bans on tobacco use outcomes among
adults. Beyond descriptive comparisons, there exists virtually no empirical evidence on how effective these
regulations would be in curtailing tobacco use at different age levels. This project will capitalize on natural
experiments exploiting variation in the timing of the adoption of bans on online e-cigarette sales and on added
flavors in all e-cigarette products, to address this critical knowledge gap and provide the first causal estimates
in the literature of these regulations. Analyses will be based on a difference-in-differences framework applied
to micro-level data from six large-scale national surveys of youth, and young adults and adults. As part of our
main aims, the proposed research will also provide some of the first evidence on how state penalties imposed
on retailers for selling e-cigarettes to underage youth and young adults are impacting e-cigarette use by these
groups and how they are obtaining their e-cigarettes. Despite the age restrictions, the considerable level of e-
cigarette use by youth indicates that the minimum purchase age laws by themselves have had limited
effectiveness. Thus, it is important to understand whether stricter penalties can reduce the overall use of e-
cigarettes.

Public health relevance
Project Relevance This research will contribute to public health by investigating the potential effects on tobacco use of two important public policies. These policies are complete bans on internet sales of e-cigarettes, and comprehensive bans on added flavors in e-cigarettes. The effects of new retailer penalties for the sale of e- cigarettes to underage buyers will also be investigated.